Social Facilitation of Emotion Regulation in Adolescence

Project Summary
Adolescents demonstrate a high need for emotion regulation [2-4], but often struggle to employ gold-
standard regulatory strategies such as cognitive reappraisal due to underdeveloped lateral prefrontal
neuroarchitecture (i.e. lateral prefrontal cortex (LPFC)), which plays a crucial role in cognitive control [5-8]. At
the same time, adolescents are exquisitely sensitive to their peers [11,13-16]. Notably, neural regions linked to
peer influence in adolescence, including ventral striatum (VS) and ventromedial prefrontal cortex (vmPFC),
mature prior to LPFC. Thus, adolescents are uniquely poised to benefit from a social intervention designed to
appropriate peer influence mechanisms towards enhancing emotion regulation efficacy. The goal of this R21
is to work with the developing brain, not against it, to utilize adolescent-emergent reward-related
circuitry (VS, VMPFC) instead of LPFC to regulate emotion in adolescents. We will administer a novel
paradigm during functional magnetic resonance imaging (fMRI) to examine whether adolescents (N = 50) and
adults (N = 50) are more effective at down-regulating negative affect when a friend provides them with
reinterpretations of negative stimuli (i.e. social reappraisal), as compared to when they reinterpret stimuli alone
(i.e., cognitive reappraisal) [12]. Specifically, we will investigate whether social reappraisal is more effective
and longer-lasting than cognitive reappraisal in down-regulating negative affect in adolescents and adults (Aim
1). We hypothesize that social reappraisal will be more effective and enduring than cognitive reappraisal in
both groups, but that this effect will be larger in adolescents given their heightened sensitivity to peers.
Furthermore, we will identify the neural mechanisms supporting social versus cognitive reappraisal and
characterize age-related differences in these mechanisms (Aim 2). We will focus on examining activation in
the amygdala, LPFC, VS, and VMPFC, as well as functional connectivity between these regions. We
hypothesize that LPFC-amygdala connectivity will support cognitive reappraisal, which will be stronger in
adults versus adolescents, whereas VS-amygdala and VMPFC-amygdala connectivity will support social
reappraisal. While VS-amygdala connectivity is likely to be stronger in adolescents than adults, VMPFC-
amygdala connectivity might not be given that this pathway is still developing during adolescence [21,76]. We
expect that social reappraisal will have a more transformative and thus longer-lasting effect on amygdala-
based representations of negative stimuli, particularly in adolescents, and will use representation similarity
analysis to test this hypothesis. Examining the efficacy and neural underpinnings of social reappraisal in
adolescents versus adults is an important step in advancing our understanding of how social contexts shape
emotion regulation neurodevelopment, with the aim of improving adolescent health and laying the groundwork
for positive emotional wellbeing into adulthood.

Public health relevance
Project Narrative Despite the high need for effective emotion regulation interventions in adolescents and the potential for peer relationships to improve emotion regulation in this age group, no research to date has examined whether peer-facilitated activation of neural reward circuitry can effectively regulate emotion in adolescence. The goal of this project is to test whether regulating emotions with help from a friend is more effective and long-lasting in adolescents than regulating alone, and to characterize age-related differences in the neural mechanisms supporting social versus cognitive emotion regulation. Examining the mechanisms underlying social emotion regulation in adolescents will advance our understanding of how social contexts shape adolescent brain development, and how peer influence can be applied towards improving adolescent health, laying the groundwork for positive emotional wellbeing into adulthood.